JHU Admin Core

ADMINISTRATIVE CORE
ABSTRACT
The Administrative Core of the Johns Hopkins O’Brien Center to Advance Kidney Health Equity (JHOC) will
provide the overall administration of the Center, leading, managing, and harmonizing all aspects of the Center
and ensuring that Center resources are shared nationally. The Administrative Core will be led by Dr. Deidra
Crews and Dr. Chirag Parikh (as Co-Directors). Their complementary research approaches underscore the
Center’s ability to enable research along the entire research continuum from bench to community. The Specific
Aims of the Administrative Core are to: 1) provide administrative support to JHOC Cores and coordinate the
Center activities to maximize resource development and dissemination; 2) collaborate with the National
Coordinating Center to prioritize external requests for resources and enhance national outreach; 3) plan and
execute an annual Summer Student Enrichment Program which leverages a long-standing partnership with a
Johns Hopkins program for students from under-resourced backgrounds; 4) foster the careers of early-stage
investigators by promoting trans-disciplinary and cross-sector collaboration, including with an established
Community Advisory Board; 5) create and maintain an updated website to communicate about center
resources; and 6) engage an Internal Advisory Committee to evaluate effectiveness and outcomes for the
Center. Each of these components will work together through the Administrative Core to enable research in
kidney health equity to thrive and expand.